Core-005

The overall goal of the Rockefeller Center for Clinical and Translational Science (CCTS) is to accelerate translational research to improve human health and to train a workforce, including new clinical and translational investigators, in methods, knowledge, and practices to best perform translational research. The Hub Research Capacity Core contributes to these goals by integrating special populations into research studies and providing participant and clinical interactions to accelerate translational research. The Core’s specific aims are: 1. To encourage the Integration of Special Populations (including children, older patients, survivors of formerly lethal childhood diseases, minority, and underserved or health disparity populations including racial, ethnic or gender differences as well as socio-economic status, urban environment, pregnant women, people with disability and other “hard-to-reach” groups) in research by: a) providing a comprehensive range of services in the new Translational Research Navigation (TRN) program to assist investigators in engaging populations and recruiting them to studies, b) collaborating with Clinical Directors Network (CDN), a Practice Based Research Network that serves a diverse patient population, c) collaborating with other CTSA hubs and CDN in the NYC Clinical Data Research Network (NYC-CDRN) to build this vital database for identifying potential participants from special populations, d) collaborating with the CTSA hubs at Vanderbilt, Scripps, Einstein, NYU, Columbia, and Weill Cornell on a series of initiatives that are developing novel methods for engaging special populations. 2. To enhance Participant and Clinical Interactions by: a) Initiating the innovative multi-disciplinary Translational Research Navigation program to accelerate the development of translational research studies and to increase access of scientists and clinicians to required regulatory knowledge, scientifically sound study designs, appropriate methods, and needed clinical research personnel and facilities throughout the “lifespan” of a clinical study, b) Providing system-wide oversight and monitoring to ensure maximal integrity of research processes and participant safety, c) Using metrics to assess the success of protocol development, implementation, progress and completion, and to drive performance improvement. We will accomplish the first specific aim by educating investigators about the benefits of integrating special populations into their studies and extending their research across the entire age spectrum. We will also assist them in identifying special populations directly and via our collaboration with CDN, since the Federally Qualified Health Center members of CDN serve a racially and ethnically diverse population of individuals, many of whom are from medically underserved populations. We will accomplish the second specific aim by providing a comprehensive Translational Research Navigation program that combines knowledge experts in a range of research elements with infrastructure systems and informatics platforms to speed protocol development and implementation of the standards of Good Clinical Practice (GCP).